Language and Executive Function in Females with ASD or FXS

PROJECT SUMMARY/ABSTRACT
Females with neurodevelopmental disabilities, including females with Down syndrome (DS), autistic females
(iASD), and females with fragile X syndrome (FXS), are significantly understudied in research. Even though,
like their male peers, females experience pervasive, lifelong difficulties with language, adaptive functioning,
psychiatric comorbidities, and academic achievement, there remains a dearth of research regarding
phenotypic development in females in these clinical groups. DS is the most common genetic cause of
intellectual disability, while FXS is the most common inherited cause of intellectual disability and the most
common single-gene cause of ASD. Both DS and FXS are associated with higher rates of co-occurring autism
compared to the general population. Research on males has identified key areas of overlap and distinction
between these three neurodevelopmental disabilities, particularly in language and cognition. Thus, studies
comparing the phenotypes of DS, FXS, and iASD in females, focusing on areas of overlap and divergence, are
particularly important because they provide the foundation for clinical and educational planning and elucidating
the mechanisms producing the phenotypes of these three clinical disorders. Executive functions are one
aspect of cognition that has received significant attention in DS, FXS, and iASD, since they are an important
contributor to real-world outcomes and particularly amenable to treatment. Both language and executive
functions are known to have a significant and pervasive impact on critical developmental outcomes, including
academic skills (i.e., literacy), adaptive behavior, and psychiatric symptomatology. The impact of language and
executive functions on these outcomes has not been explored in females with DS, FXS, or iASD. There is an
urgent need to characterize the language and cognitive phenotypes of school-age females with these disorders
to understand the nature and course of development. The proposed supplement will add a group of 20 8-12-
year-old females with DS to the parent project, which includes 8–12-year-old females with FXS (n = 70) and
iASD females (n = 70). Through two specific aims, we will determine the extent, nature, and syndrome
specificity of impairments in language and executive functions and examine their relationships. We will
determine the impact of language and executive functions on key developmental outcomes, including literacy,
adaptive functioning, and psychiatric symptomatology. The proposed study will include standardized
assessments, expressive language samples, experimental tasks, and parent report measures. The data from
this study will provide critical information for clinicians and educators working with females with DS, FXS, and
iASD and will provide data necessary for the development of targeted interventions for cognitive and language
skills directly impacting developmental outcomes.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because it contributes to a program of research focused on significantly improving the communication abilities of individuals with neurodevelopmental disorders, including females with Down Syndrome (DS - supplement), idiopathic autism spectrum disorder (iASD; parent grant), and fragile X syndrome (FXS; parent grant). The proposed study, employing a rigorous design, will investigate both language and executive functions using well-validated measures, including experimental tasks, standardized assessments, parent report, and naturalistic language sampling, to successfully achieve our specific aims. Given the prevalence of iASD (1 in 31 children) and the significant overlap between FXS, DS, and iASD, this project directly addresses the NIDCD’s mission to improve the lives of individuals with communication disorders.